Genetics and therapeutics pinpoint link between glucose metabolism and Alzheimer’s disease

Diabetes and dementia have an unexpectedly high rate of comorbidity: individuals diagnosed with diabetes
have a 1.4–2.2-fold higher risk of dementia than those without diabetes. The healthcare burden of these
diseases also differs by race/ethnicity backgrounds (higher in non-Hispanic Black individuals) and by biological
sex (higher in men for diabetes but women for dementia). Epidemiological studies have proposed shared risk
factors, metabolic disorders, comorbidities, and genetics to explain this relationship but human research in
assessing molecular mechanisms is challenging due to environmental influences. Nevertheless, Dr. Litkowski,
the primary investigator of this proposal, provided the first causal genetic evidence between diabetes and
dementia in her work with the Million Veteran Program. The long-term goal of this project is to elucidate the
mechanism by which impaired glucose metabolism leads to cognitive decline. This proposal integrates human
findings with causal testing, and preclinical interventions using a unique discovery pipeline in the Alzheimer’s
disease mouse panel (AD-BXD), a genetically diverse model incorporating AD loci known to predict cognitive
decline in human populations. The objective is to 1) confirm the genomic region Prdm10 leading to declines in
postprandial glucose metabolism in AD susceptible females fed a high fat high sucrose diet and 2) evaluate an
anti-diabetes drug, miglitol, on strains deemed to be susceptible to cognitive decline. The hypothesis is that
genetic (Prdm10) and pharmacological (miglitol) interventions will modify cognitive resilience.
This project will be conducted at the University of Michigan (UM), the #2 public research university (and #4
in overall rank) in the U.S., according to the National Science Foundation, with annual research expenditures
of ~$1.77 billion dollars and ~$970 million dollars in federally-sponsored research in 2022. UM is a premier
biomedical research institution with first-rate core facility services for its researchers, specifically the
Bioinformatics Core, Metabolomics Core, and Transgenic Animal Core, relevant to this proposal. The primary
investigator (and trainee) of this proposal (Dr. Litkowski) will have access to the extensive facilities and
equipment of the Dr. Kaczorowski Laboratory, including a state of-the-art behavioral suite outfitted for cognitive
testing (passive avoidance, Y-maze, contextual fear), a surgical suite, and 2 large animal housing rooms. The
proposal includes a detailed training plan for Dr. Litkowski mentored by her sponsor, Dr. Kaczorowski, and co-
sponsor, Dr. Bridges, both of whom have previously mentored postdoctoral fellows to become independent
investigators. The training plan establishes a timeline for achieving data acquisition proficiency to assess
glucose/insulin metabolism and cognition, and for developing and implementing innovative reverse genetics
approaches. In summary, successful completion of these aims will define Prdm10 as a causal gene, and
miglitol as an effective intervention leading to improved glucose metabolism and resilience to AD-related
cognitive decline while at the same time preparing Dr. Litkowski for a career as an independent investigator.

Public health relevance
Diabetes and dementia have an unexpectedly high rate of comorbidity with a disparity of healthcare burden based on race/ethnicity as well as sex differences. Previous studies have not deciphered the mechanisms by which genetic diversity interacts with environmental factors to explain these discrepancies. Our proposed research will take a two-pronged approach, first determining how changes in the Prdm10 gene affect dys- glycemia and cognition, and second evaluating how lifetime exposure to a diabetes drug, miglitol, rescues cognition in a mouse model susceptible to cognitive decline.